Administrative Core

F. Administration Core The Administration Core will be accountable for the progress of the BCSC towards delivering probe compounds. It will be responsible for the integration, oversight, direction and progress of the core components.